Data Management Core

SUMMARY/ABSTRACT
The Data Management Core (DMC) is designed to support survey research and analytical services to all
Projects and Cores represented in this P01.
The Data Management Core has the following specific aims:
1. Survey design, administration, and management including communication with survey firms to ensure
uniformity of protocols, programming and testing of surveys, and hosting if needed.
2. Survey data processing and production including data cleaning, data checks, construction of weights
using external population control information, and computation of derived variables.
3. Management of a secure data repository and data sharing allowing researchers to access data.
4. Advice and technical assistance, ensuring that data collected provide useful input to substantive
research questions; theoretical and simulation studies; consultation on research design, data collection
methods, preparation of and reviewing analysis plans, and conducting analyses for papers and reports.
5. Integration of data from the component projects and other sources and locating auxiliary data sets to
strengthen the inferences that can be made for the research questions of interest.
The diversity of research designs and number of collection sites require a core service to help ensure the
integrity and synergy of these projects and the quality of the data. the work of the DMC is vital to the realization
of Aim 2 of the P01, to contribute to the development of methods for monitoring response to the evolving
nicotine product landscape and associated policies. The DMC includes experts in survey sampling,
biostatistics and research methods who have extensive backgrounds in research on health behavior and the
use of tobacco and its substitutes, as well as data analysts and experts on questionnaire design and
databases.

Public health relevance
NARRATIVE The Data Management Core (DMC) will design and oversee the data collection for the surveys, administer data collection for the adult cohort, and collect data for the Emerging Products Core and the Experimental Tobacco Marketplace. The DMC will continue to produce data sets for users, to manage a secure repository of data and data access system, and to maintain a database of policies related to products delivering nicotine. Questionnaire specialists will provide support to all projects and cores around instrument development and documentation, ensuring comparability of measures across studies, and DMC personnel will perform analyses for papers and presentations, estimate parameters as input to the modelling project, provide advice and technical assistance, and serve as a hub for the efforts of analysts and data specialists of the projects.